Pulmonary and Critical Care Medicine Training Grant

Project Summary/Abstract
The University of Washington (UW) program trains scientists to perform clinically-relevant research in
pulmonary and critical care medicine. In this application, we request 8 slots to support 4 trainees each year as
part of a 4-year combined clinical and research program. We focus primarily on physician-scientists who are
able to conduct research across the continuum of biomedical investigation, from basic research in the
laboratory to translational, patient-oriented and implementation research. An interdisciplinary approach
prepares trainees for academic careers characterized by independently funded research and a commitment to
training others. The program is distinguished by the quality and expertise of the training faculty, a structured
and successful approach to mentoring, and the integration of multiple disciplines and diverse research
methodologies leading to outstanding success in training independent scientists. Research training is
conducted through two primary pathways: Basic Science and Health Outcomes. Within each pathway,
experienced and committed mentors provide a rich range of research opportunities, research study groups
expose the trainee to a broad range of methodologies and research topics, and didactic course work enriches
the research training experience. The Basic Science pathway provides trainees with the opportunity to master
a wide variety of cutting edge research methodologies. The Health Outcomes pathway generally includes
completion of a master's degree in either the Department of Epidemiology or Health Services. Training in
translational research occurs at the confluence of the two pathways. Our success in training physician-
scientists is founded on a highly structured, yet flexible process to aid fellows in selecting research mentors
and projects and guide them through the mentoring process. Prior to beginning research training, trainees 1)
are counseled by training faculty leadership, 2) participate in a senior fellow-driven research symposium and 3)
have dedicated “sabbatical weeks” each fall and spring to conduct interviews with potential mentors. Once in
the research training program, formal mentoring committees support and track the fellows' progress. Training
includes instruction in manuscript and grant writing and a formal review process for grants and research
presentations. A series of evaluation metrics monitor progress of the trainees, mentors, and program
leadership. We have developed and articulated core principles of mentoring that are used to guide and
evaluate training. Through a commitment to continuously review and improve our program, the training
program has kept pace with advancing biomedical research and the changing needs of our trainees. Over the
past 15 years, we have retained nearly 60% of our physician-scientists in full-time academic positions, and our
trainees perform exceptionally well compared to other DLD-supported T32 programs, with nearly double the
number of K- and R-awards per trainee.

Public health relevance
Project Narrative The program focuses on training physician-scientists to become independently funded researchers and contributors to team science. It stresses the conduct of clinically relevant research in an ethical and scientifically rigorous manner and has an ongoing commitment to attract and train individuals from underrepresented minorities. The program highlights a structured mentoring and career development process and imprints a culture of mentoring and career development among its trainees.